Mi QUIT CARE (Mile Square QUIT Community-Access-Referral-Expansion)

Abstract
Demonstrating the feasibility, effectiveness, and cost-effectiveness of electronically delivered smoking
cessation interventions via patient portals in Federally Qualified Health Care (FQHC) settings has the potential
for wide-spread dissemination and significant public health impact. on patient populations with demonstrated
high rates of smoking. The specific aims of are to:
UG3: Aim 1. Examine the burden of tobacco use and its influence on pulmonary health disparities (lung
cancer, COPD, and asthma) in the patient population and the economically disadvantaged and racially
segregated catchment areas of Mile Square Health Centers.
Aim 2: Evaluate knowledge, attitudes, barriers and facilitators to: smoking cessation, engagement with the
tobacco quit line, linkage to the tobacco quit line via a patient health portal and receipt of patient navigation to
facilitate access to the tobacco quit line among MSHC patients and health care providers..
Aim 3: Evaluate the use of community engagement strategies to increase uptake of the UI Health Patient
Portal among low-income patients receiving care at Mile Square Health Center.
Aim 4: Test the acceptability, feasibility, and capacity of Mile Square Health to deliver Mi Quit CARE, an
evidence-based and multi-level intervention to increase engagement with the quit line via the UI Health Portal.
UH3: Aim 1: Determine the effectiveness Mi Quit CARE compared to standard of care in increasing patient
engagement with the Illinois tobacco quitline and subsequent smoking cessation outcomes.
Aim 2: Evaluate the scalability of Mi Quit CARE to multiple sites within the UI Health FQHC Mile Square clinic
network and by translating the intervention to Spanish.
Aim 3: Examine the cost effectiveness of Mi Quit CARE on smoking cessation outcomes compared to
standard of care among a high risk FQHC population.

Public health relevance
Project Narrative Low-income populations are disproportionately burdened by tobacco use and carry a greater burden of pulmonary health inequalities related to smoking. Despite widespread usage by populations burdened by tobacco use, Federally Qualified Health Care (FQHC) systems are an under-utilized model for reducing pulmonary and other smoking-related health inequalities among disadvantaged populations. The purpose of this study is to demonstrate the feasibility, effectiveness, and cost-effectiveness of electronically delivered smoking cessation interventions via patient portals in a network of FQHC clinics.